CHEETAH Center for the Structural Biology of HIV Infection, Restriction, and Viral Dynamics

CORE SUMMARY
We aim to “engage and support the next generation of HIV structural biology researchers” by creating effective and diverse
training opportunities. Our Developmental Core will accomplish this by implementing a series of training and development
programs that will include four Components: 1) a Collaborative Development Awards Program designed to support talented
young independent researchers who will benefit from and contribute to CHEETAH Center research projects and capabilities,
2) a summer, journal club-style Seminar Series that will expose Center trainees to the current HIV-1 literature and help hone
their scientific presentation skills, 3) a Visiting Scholar Program for Center trainees that will include online training in the
theoretical underpinnings and practical aspects of different biophysical and structural methods, followed by a 1-2 month
“hands on” experience in which trainees will visit a Center lab or other training site to apply one of these methods to a
problem of interest, and 4) Other Training Activities that will include virtual visual communication workshops for Center
trainees that will provide them with practical guidance on creating outreach videos, animations, figures, and
posters/presentations.

Public health relevance
CORE NARRATIVE Our Developmental Core will engage, train, and support the next generation of HIV researchers by providing Collaborative Development Awards to talented young independent researchers, running a journal club-style Seminar Series in which Center trainees will present current HIV-1 research papers, offering a Visiting Scholar Program for Center trainees that will include online training and lab visits to gain “hands on” experience and expert guidance, and providing Other Training Activities that will include visual communication workshops for Center trainees.